GLYCOXIDATION AND DIABETIC RETINOPATHY

The aim of the proposed study is to test the "glycoxidation hypothesis", which states that variations in oxidative stress among diabetic patients modulate the consequences of long-term hyperglycemia, specifically in determining the development of microvascular complications. To determine levels of glycoxidation products in skin collagen from complication-prone and complication-resistant diabetic patiens.